The development of a flexible carbon fiber penetrating nerve cuff and cortical array for neural recording, stimulation, and neurochemical detection

Penetrating electrodes for electrophysiology recording and stimulation are critical to understanding neurological
disorders and mental health conditions. However, the chronic viability, stability, and safety of current
multichannel electrode options are not ideal for clinical translation due to their size, material composition, and
rigidity. Typically made of metal or silicon, these electrodes cause substantial damage upon insertion, evoke an
immune response, and often deflect or move from the desired brain region.
Carbon Fiber (CF) offers solutions to many of these issues. BRAIN Initiative sponsored research at the University
of Michigan has greatly improved the use and production process of CF microelectrode arrays demonstrating
that penetrating CF electrodes are highly biocompatible, produce minimal insertion damage, provide outstanding
single-unit recording, improve electrode stability, have high signal-to-noise ratio, and high charge injection
capacity for chronic stimulation. The size of the CFs also makes them extremely flexible while still penetrating
neural tissue, including nerves. However, current CF array designs are still connected to a rigid PCB that contacts
neural tissue that can cause physical damage and limit conformity to the neural surface. A flexible interface
connecting the CFs to the electronics would enhance use of CFs in the brain and allow better conforming to
unique neural surfaces.
In this Phase I STTR Spike Neuro is partnering with the University of Michigan to combine their CF technology
with Spike Neuro’s proprietary polyimide surface arrays to create a highly flexible 3D penetrating array. Our PI,
Dr. Julianna Richie, PhD, has been a key developer of this CF technology, including early evaluations of their
use with a flexible interface. Through this Small Business Transition Grant for Early Career Scientists, she will
receive mentorship and support to transfer her developments out of the lab and into to a commercial product.
Mentors from Spike Neuro and the University of Michigan will provide both technical and commercialization
guidance to achieve the aims of this project. The planned mentorship objectives will also support Dr. Richie’s
transition from an academic researcher to an independent scientist in an industry environment.
In Aim 1, Spike Neuro surface arrays will be modified to create vias for CFs to be inserted and secured to the
array. The connection will be tested through mechanical brushing, agar insertion tests, and electrochemical
impedance spectroscopy (EIS). In Aim 2, we will develop custom lithography mask to optimize an array for CF
integration. In Aim 3, we will perform ex vivo testing in retina to evaluate the flexible CF array’s ability to conform
to biological tissue with complex geometry and its electrophysiology performance in a biological environment.
At the conclusion of this study, we will have demonstrated the proof-of-concept of a flexible carbon fiber 3D
penetrating array. For future work we will leverage the commercialization training support of the grant mechanism
to identify key targets for future designs and explore use of the array for neurochemical detection.

Public health relevance
Narrative Penetrating electrodes greatly enhance our ability to study and interact with neurological structures underlying many mental health and other neurological disorders. However, there is a critical need for improved neural interfaces that are suited for chronic implantation to support the development and clinical translation of devices to treat neurological conditions such as drug-resistant depression, anxiety, and drug abuse. Spike Neuro and the University of Michigan are partnering together to develop a flexible, 3D, carbon fiber penetrating array for electrophysiology applications in complex and fragile biological systems with excellent biocompatibility, chronic performance, and potential for clinical translation.